Core--Teaching and training

Dr. Gerhardt will direct the operation of this Core. This Core will involve the training and teaching of one Post Doctoral Scholar and one Graduate Assistant. These individuals will be recruited through a national search. Once recruited, both will work with the Project of the Center.